IGF::OT::IGF: Task Order TO No. HHSN26800003, titled Recipient Epidemiology and Donor Evaluation Study III REDS-III Central Laboratory - Characterization of blood transfusion-transmission of Zika viru

The purpose of this study is to support non-human primate research designed to understand the transfusion-transmissibility, viral dynamics, and efficacy of pathogen-inactivation technologies to reduce transfusion-transmissibility of Zika Virus.